Biodegradable Elastomers and Resorbable Synthetic Vascular Grafts

Project Summary
Occlusive artery diseases are a leading cause of death worldwide. Only in the U.S., there are
approximately 400,000 coronary artery bypasses and 460,000 peripheral artery bypasses performed each year.
Autografts are the gold-standard treatment. However, approximately 1/3 of these patients are unable to take this
treatment because of limited autologous resources. Nondegradable grafts (e.g., PET and ePTFE) have been
alternative to the autografts over the years, but they perform poorly in small arteries (< 6 mm) due to thrombosis,
stenosis, and low patency rate. On the other hand, bioresorbable grafts have been proposed for in situ arterial
regeneration using the host regenerative capacities. The complications occurred in the nondegradable grafts
can be minimized. However, none of the currently existing biodegradable polymers have produced a clinically
useful resorbable graft.
In this proposal, we seek to synthesize new biodegradable functional polyester elastomers and use to
engineer fully resorbable synthetic grafts with tunable degradation, mechanical properties, and hydrophilicity.
We expect the fully remodeled grafts can grow along with native arteries, which is particularly important for
pediatric patients. There are three main objectives in this proposal. Objective 1: Design, synthesis and
characterization of the biodegradable functional polyester elastomers using endogenous and biocompatible
monomers. Objective 2: Engineer anti-thrombotic fibrous grafts with tunable degradation and mechanical
properties. Objective 3: Evaluation of candidate grafts in rat abdominal aorta interposition models for in situ
arterial regeneration. Data from this project will be used to optimize the graft parameters for large animal studies
in the future, given a quicker degradation and slower regenerative capacities in large animals. Undergraduate
students including underrepresented students will be recruited and trained to conduct research in this project,
such as material synthesis and characterizations, graft fabrication and characterizations, cell culture studies, and
tissue section, staining and data analyses, among others.

Public health relevance
Project Narrative Nondegradable grafts (e.g., PET and ePTFE grafts) have been used for replacement of occlusive arteries in those patients who are unable to take autograft treatment, but the nondegradable grafts show limited uses in small arteries (< 6 mm) because of thrombosis, stenosis, and low patency rate. This project seeks to design bioresorbable synthetic vascular grafts which are implanted orthotopically to replace the occluded segment for in situ arterial regeneration using the host regenerative capacities. The bioresorbable graft can be fully transformed into a living conduit by host cells, and integrate with the native arteries with a similar structure and performance.